Replacement of PET and MRI Scanners for Small Animal Imaging

Summary / Abstract
This is an application for funding to purchase a new, integrated MRI-PET scanner for animals that will replace
two obsolete, separate systems, an MRI and a microPET scanner. Our 4.7T Varian/Agilent MRI scanner has
been in continuous use for 19+ years, while our Siemens Inveon PET scanner is >11 years old. The current
electronics and console of the Varian MRI are no longer state-of-the-art, their limited capabilities are affecting
productivity, and the system is no longer supported by the manufacturer (Varian/Agilent). The PET system
would replace an obsolete Siemens Inveon PET/CT scanner that is also no longer supported by the
manufacturer and which is highly unreliable in use and can no longer perform CT imaging. For both systems
there have been no software upgrades for several years, replacement parts are scarce as the vendors are no
longer in the animal scanner business, and overall the reliability and capabilities no longer meet the demands
of our core users. The current 4.7T magnet would be replaced by a 7T magnet, with an accompanying gain in
overall signal to noise ratio, greater spectral dispersion (e.g. for MRS and CEST), increased sensitivity to
BOLD effects, and improved image quality. The new magnet would not use cryogens, so there would be
considerable savings in operating expenses, and we would be insured against shortages of liquid helium. The
PET insert would have an axial FOV of 80 mm, large enough to accommodate small, non-human primates and
large rodents. The integrated scanner will be capable of simultaneous MRI and PET acquisitions, allowing new
types of studies to be performed with accurate co-registration between modalities. PET studies will benefit from
the availability of a large range of radiotracers obtainable from our research-dedicated cyclotron and
radiochemistry laboratories. The device will be used by at least 22 established investigators, all of whom are
already experienced users of animal imaging, in over 30 NIH-funded research applications and training
programs. These research projects include applications in cardiac physiology; neuroscience (including studies
of the architecture and functional organization of the brain and spine in non-human primates, as well as the
actions of novel pharmaceuticals); cancer (including the study of tumor biology and treatment effects); lung
disease (especially the detection of fibrosis); bone disorders; and basic imaging science. The projects of the 16
Major Users would require approximately 65% use of the availability of the instrument, the 6 Minor Users and
two Center Core programs would require 16%, and the remaining time available would be used for exploratory
research and new directions. The scanner will be housed and managed within the Vanderbilt University
Institute of Imaging Science, and will be a primary research resource for a large number of experienced
imaging scientists and trainees. The instrument will be supported by an established group of imaging experts
and support staff. A comprehensive plan has been developed for the financial and technical support of the
scanner as well as for its management, and the system is assured of strong institutional support and oversight.

Public health relevance
Gore, John C. Project Narrative This proposal aims to replace two aging instruments, an MRI system that is 18 years old and a PET scanner that is >10 years old, with an integrated MRI-PET scanner that will be used for imaging small animals in diverse applications. Neither of the current devices are supported by their manufacturers, they cannot be upgraded or maintained, and their performances are no longer state-of-the-art. The new system will be especially suited for studies of non-human primates and rodents in which high spatial resolution and high sensitivity are essential.